Identifying Genomic and Microbial Contributions in Early Childhood-Inflammatory Bowel Disease

Project Summary/Abstract
Inflammatory bowel disease diagnosed before age 6 years can be distinguished from older onset pediatric and
adult IBD by its unique phenotype of severe morbidity, poor response to conventional therapies, greater duration
of disease, and its rapidly increasing prevalence. This population is further divided into those diagnosed <2 year
of age, infantile IBD, and children diagnosed between 2 and 6 years old, whom we refer to as early childhood
IBD for this proposal. While pediatric IBD is a complex polygenic disease, we and others have identified causative
monogenic defects in infantile IBD. However, little is understood about the pathogenic mechanisms in early
childhood IBD. The underlying hypothesis of this proposal is that patients with early childhood IBD have a unique
host genomic background coupled with early life exposures. This interaction leads to a dysfunctional dynamic
between the immune response and the intestinal microbial community structure. The PI will utilize this career
development and research plan in order to gain skills and establish collaborations which will allow her to develop
future translational studies leveraging large data sets to identify future therapeutic targets to improve treatment
outcomes for early childhood-IBD.
Using cutting edge technology, we will generate genomic and microbiome data to study children with early
childhood IBD. In Aim 1, the PI will identify the role of both rare and low frequency variants using whole exome
sequencing and calculate the polygenic risk score based on known IBD susceptibility loci in order to characterize
the genetic burden of the early childhood IBD phenotype. In Aim 2, stool samples will be collected during the
first 8 weeks of initiating IBD treatment in 100 newly diagnosed early childhood IBD patients in addition to
collecting data regarding environmental exposures. Shotgun metagenomic sequencing will be used to discern
the microbial community structure at each time point. The baseline microbiota will be correlated with early life
environmental exposures and the longitudinal microbiota will be analyzed in the context of changing disease
activity. As part of her career development plan, this research plan with allow the PI to refine and acquire skills
with the support of her mentors, receive hands on training from her collaborators, enroll in formal coursework,
and participate in multidisciplinary seminars and conferences to prepare her for a future career as an
independent investigator.

Public health relevance
PROJECT NARRATIVE Children with inflammatory bowel disease diagnosed between age 2 and 6 years have a severe, chronic disorder, often refractory to conventional therapy and whose incidence is rapidly increasing. The use of advanced technology in this research proposal will allow for improved understanding of the genomic and microbial contributions of IBD in this age group in order to identify more precise targets for therapies and improve these children’s quality of life.